Defining the onset and regulation of myogenic upper urinary tract physiology

Abstract
Impaired urinary outflow that causes damage to the urinary tract and kidney is a major cause of kidney disease, which affects 15% of the population and costs $100B annually. For instance, hydronephrosis, a pressure mediated dilation and damage of the renal tissues, is the leading cause of pediatric kidney failure. Major gaps remain in our understanding of the causes that underlie impaired urinary outflow and urinary tract damage. For instance, approximately 50% of all urinary tract dilation occurs in the absence of a physical obstruction, yet the functional abnormalities causing these cases remain obscure. Indeed, the upper urinary tract (UUT) is a continuous muscular organ that contracts to propel waste from the kidney to the bladder. Defects in this peristaltic process, such as vesicoureteral reflux (VUR), or retrograde backward urine flow from the bladder to the kidney, are pathological. VUR affects 2% of children, and can lead to urinary tract infections, hydronephrosis, and chronic reflux nephropathy that leads to end-stage renal disease in 10-25% of cases. Despite the essential physiological role of the UUT, the mechanisms driving UUT peristalsis remained unknown. Our group discovered that HCN ion channels underlie UUT pacemaker activity, that HCN+ pacemakers co-express T-type Ca2+ channels that control contractile rate, and most recently, that the HCN+ pacemakers are evolutionarily conserved and drive peristalsis of the unique multicalyceal UUT exhibited by humans. To date, however, the role of pacemaker defects in functional urinary tract disorders remains elusive. Thus, the overall goal of this proposal is to provide a mechanistic framework of UUT physiology, as a critical step to developing diagnostics and drugs to treat conditions such as VUR and hydronephrosis. To fill the current knowledge gaps, we will use a novel mutant mouse model that exhibits UUTs that lack pacemakers, exhibit normal smooth muscle, and develop VUR and hydronephrosis. We will use this novel mouse model to define the pathophysiology of pacemaker defects that cause urinary dilations. In aim 1 we will define the transcriptional signaling mechanisms that are required for pacemaker formation and functional UUT peristalsis. In aim 2, we will define the transcriptional protein complexomes that assemble to control UUT pacemaker development. Notably, the transcriptional complexomes required for UUT formation remain a major knowledge gap in our understanding of the UUT. Taken together, the proposed studies will provide critical insight into functional peristaltic defects that impede urinary outflow, and results will generate new genetic and protein markers that can serve as putative targets for future diagnostics
and treatments for UUT pathologies, such as VUR and hydronephrosis.

Public health relevance
NARRATIVE The upper urinary tract exhibits peristaltic contractions that propel wastes from the kidney to the bladder. Defects in upper urinary tract peristalsis, such as vesicoureteral reflux, are prevalent and associated with a high morbidity. In this proposal, we will define the signaling mechanisms that underlie upper urinary tract peristalsis defects, as well as identify the potential of drugs to treat these defects.